A core transcription factor complex of the aryl hydrocarbon receptor

The objective of this project is to investigate a core transcription factor (TF) complex of the AHR (aryl
hydrocarbon receptor) that we discovered by analysis of high-content Chromatin Immunoprecipitation-DNA
Sequence (ChIP-Seq) data of the Encyclopedia of DNA Elements (ENCODE) project, a public research project
to identify all functional elements in the human genome. In this project we will validate this complex, determine
its physical organization and function, and evaluate whether this complex is conserved across cells and
species. The AHR is best known as a ligand-activated transcription factor (TF) with important roles in the
toxicity of dioxin-like compounds (DLCs) including cancer, birth defects and immunosuppression, and the
regulation of enzymes such as the cytochrome P450 family 1 members that can activate procarcinogens.
Moreover, recent studies demonstrate key roles of the AHR in the regulation of cell homeostasis,
differentiation, aging and cancer. In this exploratory project we propose two specific aims: Aim 1. Validate the
core TF complex of the AHR and determine its function and conservation across cells and species. Aim 2.
Elucidate the regulatory mechanisms and biological functions of the core TF complex of the AHR. Together,
these proposed studies should markedly improve the fundamental knowledge of the mechanisms impacting
AHR-regulated transcription towards the long-term goal of understanding how this receptor contributes to
important cellular processes in health and disease.

Public health relevance
We will investigate a core transcription factor complex of the aryl hydrocarbon receptor (AHR) that we discovered by analysis of high-content data of a public research project (ENCODE) designed to identify all functional elements in the human genome. Because of the importance of the AHR in regulating response to many types of environmental pollutants, the results of these studies should markedly improve the fundamental knowledge of the mechanisms impacting AHR-regulated transcription, thus providing an improved understanding of how this receptor contributes to important cellular processes in health and disease